Profiling of adenosine to inosine editing in single neurons

Adenosine to inosine (A-to-I) editing is a post-transcriptional modification which is prevalent in the developing
nervous system. This chemical modification is catalyzed by adenosine deaminases (ADARs) acting on double-
stranded RNA. Because inosine is structurally similar to guanine, A-to-I editing leads to inosine base pairing with
cytosine and can change the encoded amino acid. A-to-I modification of many key neuronal mRNAs changes
properties of their encoded proteins, including ion channels and mediators of synaptic transmission, signal
transduction, and intracellular trafficking. Typically, editing increases as the brain matures during embryonic
development, with less editing found in stem and neuronal progenitors and more editing in mature neurons. A-
to-I editing is essential for normal brain development and abnormal editing has been associated with a number
of diseases, including epilepsy, amyotrophic lateral sclerosis, psychiatric disorders, developmental disorders,
and encephalopathy. The development of next generation sequencing approaches has enabled identification of
A-to-I editing sites in different tissues. These approaches have identified specific neuronal target transcripts and
the extent to which they are edited (editing efficiency varies widely and depends on transcript identity). Most
mRNA target edit sites and their overall editing frequency are known. However, whether editing efficiency varies
in different types of neurons within tissues and what fraction of a given transcript is edited in single neurons is
not known. Recent developments in transcriptomic analysis of single cells allows assigning of individual neurons
to various subtypes. However, common single cell RNA-sequencing (scRNA-seq) platforms, like 10x Chromium,
use high-throughput short-read sequencing (e.g. Illumina Sequencing) to preferentially sequence the 3’UTR
portion of transcripts to assign gene identity. As such, this approach does not allow comprehensive identification
of editing events in coding regions of transcripts. On the other hand, approaches like Iso-Seq from Pacific
Biosciences (PacBio), enable highly accurate, long-read sequencing (up to 15 kb), and do cover full transcripts
in scRNA libraries. However, Iso-Seq read depth is too low (mostly due to sequencing costs) to sample enough
transcripts per cell to assign detailed molecular identities. The goal of this proposal is to develop a methodology
allowing for the simultaneous analysis of A-to-I editing sites in targeted RNAs (via long-read sequencing) in
specific neuronal cell subtypes (characterized in detail via short-read sequencing). We will then benchmark our
approach by performing a bulk RNA-seq in the same neuronal subtypes. Because multiple studies implicate A-
to-I editing alterations in neurological and neuropsychiatric disorders, classification of A-to-I editing on a single
cell level will enable a better understanding of disease pathogenesis and better targeting of potential treatments.

Public health relevance
Multiple studies implicated A-to-I editing alterations in neurological and neuropsychiatric disorders. However, precise characterization of edited RNAs is necessary to provide mechanistic insights into these disorders. In addition, better characterization of editing events will allow use of this information as disease biomarkers as well as for identification, classification, ranking, and functional characterization of disease phenotypes.